Training and Dissemination

PROJECT SUMMARY - TRAINING AND DISSEMINATION
The goals of training and dissemination under LONIR are to provide a comprehensive arsenal of materials
needed to instruct researchers both on the theory and philosophy of image analysis, computational anatomy and
multidimensional modeling, as well as the specific applications of our sophisticated software tools. LONIR has
enjoyed a rich history of successful training efforts and the dissemination of information on the use of our high-
caliber software solutions. Under our new LONIR award period, we will continue with these essential efforts,
remaining responsive to our constituency as well as incorporating the new advances to be developed as
described in the Specific Aims our overall and TR&D research plans. Our LONI P41 Resource activities in
training and dissemination will specifically involve: 1) Workshops, both international and domestic; 2) Connection
to formal university training programs; 3) An enhanced visiting scholar series; 4) Enrichment of LONIR website
content; and 5) undertake the dissemination of graphical and video media, lectures, and scientific posters, tools,
and protocols. Moreover, we will integrate our activities with several appropriate T32 Training Programs to
include the activities of the LONI P41 Resource. All in all, our LONIR training and dissemination plans are ideally
suited to providing the neuroimaging community with instruction on the leading-edge of brain data science
research.

Public health relevance
PROJECT NARRATIVE - TRAINING AND DISSEMINATION The intention of training and dissemination under LONIR is to provide a complete battery of the materials needed to educate investigators both on the theory and philosophy of image analysis, computational anatomy and multidimensional modeling, as well as the specific applications of software developed as part of the LONI P41 Resource.